NHGRI/DIR Flow Cytometry Core

The Flow Cytometry Core of the National Human Genome Research Institute has the goal of providing all NHGRI investigators access to high quality flow cytometry services that enhance the scope and breadth of their scientific research. Services provided by the Core include planning, design, execution, and analysis of experiments.
In the genomics era flow cytometry has become valuable in genome editing experiments. It serves as a critical tool in gene-editing and cell engineering, enabling functional cellular analysis, and enrichment of targeted subpopulations, which are essential components of the Core’s research.

The Core is equipped with one BD FACS ARIA Fusion enclosed in a biosafety cabinet - five laser, 21 color instrument, one BDFACSAria; one SONY SH800 chip based benchtop sorter in a biosafety cabinet capable of six color analysis one thirteen color Beckman Coulter CyotFLEX S analyzer, one 21 color Beckman Coulter CytoFLEX LX analyzer; a Miltenyi Auto MACS for magnetic cell separation and a HESKA HT5 for murine CBC/Differential analysis.
Core personnel are available for training, development, and project execution.

The Flow Cytometry Core is currently staffed by Stacie Anderson (Core Director,100% effort, GMBB), and Martha Kirby (Associate Director, 100% effort, GMBB). These investigators run the sorters, maintain the analyzers and other equipment and provide expert advice on design and execution of experiments.